Validation of the TAPS-Electronic Spanish Platform (TAPS-ESP): A Technology to Improve Access to Substance Use Screening and Reduce Behavioral Health Disparities in Hispanic Primary Care Patients

ABSTRACT
Language accessibility and cultural awareness are essential elements of quality healthcare. Individuals with
limited English proficiency are less likely to self-identify a need for behavioral health services, which results in
longer duration of untreated disorders. Accurate identification, diagnosis, and treatment are entirely dependent
on a linguistically-accurate screening and assessment, especially for sensitive topics such as substance use.
Substance use screening in primary care is now recommended as an evidence-based practice for all adults,
but remains underutilized. The shortcomings of existing substance use screening tools led the NIH to develop
and validate the “Tobacco, Alcohol, Prescription drug, and illicit Substance use Tool (TAPS Tool), a two-stage
screening and brief assessment tool to detect substance use problems in primary care. As part of our Phase I
NIMHD STTR project, our team led a research-driven adaptation of the TAPS Tool into a Spanish language
version, and developed a mobile/tablet technology platform to support its deployment in healthcare settings
(the TAPS-Electronic Spanish Platform, or TAPS-ESP).
The current Phase II SBIR study builds on this effort. For Aim 1, we will integrate the TAPS-ESP into the
existing health information technology infrastructure of Baylor Scott and White Health (BSWH), a large
healthcare system in Texas that serves a large number of Spanish-speaking patients. For Aim 2, we will
conduct a large-scale validation study of the TAPS-ESP against a widely-used diagnostic reference standard,
other screening tools, and oral fluid/saliva drug testing in a large sample of 1,000 Spanish-speaking primary
care patients. Separately, for Aim 3 we will conduct a real-world implementation trial in which 10 primary care
providers receive training on the TAPS-ESP, incorporate it into standard care, and complete a qualitative
interview on barriers and facilitators of implementation from a provider workflow perspective.
To the best of our knowledge, this will be the largest validation study of a Spanish-language substance use
screening tool in the US to date. The project could expand access to evidence-based, linguistically-accurate
substance use screening and brief assessment for an underserved population that experiences significant
behavioral health disparities. Thus, the project could have high scientific and public health impact, along with
strong commercialization potential.

Public health relevance
Project Narrative The TAPS Tool is a screening and brief assessment tool to detect unhealthy substance use in primary care. Building on our work to develop a Spanish language version of the TAPS Tool in a technology platform (the TAPS-ESP), in this Phase II SBIR project we will (1) integrate the TAPS-ESP into the existing health information technology infrastructure of a large healthcare system, (2) conduct a rigorous large-scale validation study of the TAPS-ESP, and (3) examine barriers and facilitators of real-world implementation from a provider workflow perspective.